IGF::OT::IGF THE DEVELOPMENT OF EVALUATION METRICS FOR EXTRAMURALLY FUNDED PROGRAMS, PROJECTS, AND INITIATIVES FOR THE EPIDEMIOLOGY AND GENOMICS RESEARCH PROGRAM.PERFORMANCE 9/15/2014 THROUGH 09/30/20

Modification to add additional in-scope work in the amount of $50,000 for Goal 2, Task 1-2 and Goal 3, Task 1, and Recommendations, Goal 4, Task 1-3.